Predictive Models for Opioid Use Disorder Using Genomic, Social, and Clinical Factors

PROJECT SUMMARY / ABSTRACT
The opioid crisis is a major public health problem in the United States. Over the past two decades, opioid use
and abuse have increased dramatically, with over 5 million people in the United States using prescription
analgesics without medical need or prescription. This has resulted in a significant increase in opioid-related
deaths and addiction rates, with the crisis having a profound impact on individuals, families, and communities.
The proposal aims to develop machine learning-based predictive models for opioid use disorder (OUD)
leveraging genomic, social, and clinical factors. The project will utilize the diverse and equitable AllOfUs
database to identify novel genomic markers associated with OUD in patients with and without co-existing pain
conditions. A significant advantage of the AllOfUs database is the diversity of the patient population and clinical
samples – over 50% of the population is considered underrepresented. This will be achieved through genome-
wide association analysis to identify novel single nucleotide variants, copy number variants, and/or structural
variants. The project will also use machine learning techniques to develop predictive models that classify the risk
of OUD, integrating various data types such as clinical factors, social factors, and genomic data. The project
aims to identify key features that aid in the development of improved models for predicting the risk of OUD.
The first specific aim of the proposal is to identify associations between genomic profiles and OUD. The project
will focus on patients with or without co-existing pain conditions and identify novel genetic markers associated
with OUD in each of these unique patient populations.
The second specific aim is to develop predictive models using machine learning techniques to classify the risk
of OUD. The models will integrate social, clinical, and genomic data to provide clinicians with a tool to risk stratify
their patients.
The project aims to develop robust machine learning-based models predicting OUD and visualize the individual
features' impacts on model performance to provide understanding of which factors are most impactful to
predicting the outcome.

Public health relevance
PROJECT NARRATIVE Opioid use disorder remains a significant public health crisis with poor clinical decision support- predicting use is still challenging and ineffectively accounts for the constellation of factors that play a role in escalation and/or dependence. We will apply a machine learning approach leveraging the diverse and equitable AllOfUs dataset which will integrate genomics, social, and clinical factors to predict development of opioid use disorder. Novel biomarkers will be elucidated to aid in future clinical support for these at-risk populations.